Proteolytic Mechanisms Mediating Cell State Transitions in Development and Stress Responses

Project Summary
Emerging findings by us and others have revealed critical non-lethal functions of caspases across diverse
animal phyla. Our published and unpublished findings indicate marked roles for caspases in ensuring
multiple aspects of development including cell-cell communication, cell migration, protein homeostasis, and
regulating stress responses. Moreover, our data indicate that a caspase target expressed in the same cell
at the same time as the caspase may not be acted upon by the caspase until a specific developmental time
point suggesting additional layers of regulation. It is not known how specific non-lethal caspase functions
are mediated. Based on our recent findings, it is likely that caspases require other components, such as E3
ligases, to execute these non-lethal functions. We hypothesize that caspases function in complexes with
other proteins that confer non-apoptotic specificity according to developmental stage, tissue type, and
environmental status. Over the next five years, the critical goals for my lab are to: 1) identify how caspase
modulates p38 MAPK-mediated signaling network to support neuronal integrity, 2) understand how UBR E3
ligases coordinately regulate cell fate, and 3) identify novel caspase functions in gene expression and
metabolic regulation. Our proposed cross-disciplinary studies include genetic screens, biochemical
analyses, translatomics, proteomics, metabolomics, and structure-function studies. The objective of the
proposed studies is to understand how proteolytic mechanisms mediate diverse cellular regulatory functions
in response to developmental or environmental cues.

Public health relevance
Project Narrative Emerging findings by us and others revealed unexpected non-lethal death functions of caspases. We want to understand how these non-canonical functions along with other proteolytic mechanisms are regulated to account for the developmental stage, tissue type, and environmental status of an organism. The findings from this study will help us to understand mechanisms of caspases in developmental and stress responsive cell state transitions that are important to ensure viability.